Core-005

The goal of the Hub Research Capacity Core of the Center for Clinical and Translational Science and
Training (CCTST) is to support the clinical and translational research enterprise of the future. As outlined in the
FOA, the Hub includes two cores: Participant and Clinical Interactions (PCI) and Integrating Special
Populations (ISP). The PCI Core will focus on improvement of infrastructure and processes to conduct clinical
and translational research, with an overall goal to enhance the experience of participants and investigators.
This will be accomplished through the following Specific Aims: 1) engage stakeholders in conducting clinical
and translational research; 2) promote development of a diverse, multidisciplinary workforce of the future; and
3) optimize the processes to conduct high-quality research studies in a safe environment. Examples of the
approaches to accomplish these aims include: engaging stakeholders through conducting biannual surveys;
extending clinical and translational research capabilities to underserved populations and those with health
disparities through a mobile unit; developing skills training in clinical research to provide knowledge on clinical
research implementation and the resources available to study investigators and study teams; streamlining
protocol assessment, review, approval, and monitoring; and utilizing state-of-art Clinical and Translational
Research Center (CTRC) infrastructure and highly qualified research personnel to conduct first-in-man
treatments such as gene therapy or use of organoids for treatment of diseases. The CCTST has a strong
history of effectively integrating special populations into clinical and translational research. Our Integrating
Special Populations Initiative (ISPI) will build on well-developed programs by increasing the participation of
special populations in research design and equipping research teams with the tools needed to overcome
barriers to research participation for special populations. To achieve this goal, we will 1) support innovative
strategies for engaging underrepresented populations in research studies; 2) expand infrastructure support for
integrating special populations into research; and 3) optimize recruitment of special populations using
biomedical data. These efforts will result in the development of a network of health care providers, community
partners, and researchers empowered to launch new research that will impact the most vulnerable and hardest
to reach special populations experiencing the greatest burden of health disparities.